CF 2: Biostatistics and Bioinformatics Core

Core 2: Biostatistics and Bioinformatics
ABSTRACT
The Biostatistics & Bioinformatics Core will support investigators of the Soft Tissue Sarcoma SPORE in
the computational and statistical aspects of their research efforts, including the design and analysis of
laboratory experiments, molecular profiling assays, and clinical trials. In laboratory experiments, core
members will assist in the formulation of the experimental design and in the analysis and interpretation
of the data at the conclusion of the study. The core will also assist in the large-scale molecular
characterization of cell line and human tumor samples to identify predictors of tumor characteristics,
drug response, and survival. In the clinical trial design phase, a core member will conduct a protocol
review with the principal investigator; based on this review, a statistical section for the protocol will be
provided, outlining major scientific objectives, population to be studied, primary and secondary
endpoints, experimental design, analysis plans, and a targeted sample size justified in probabilistic
terms; at the conclusion of the trial, data analyses will be performed to assess outcomes of the primary
and secondary endpoints stated in the protocol. The core will perform statistical and bioinformatic
analyses using appropriate state-of-the-art methodologies, and will develop alternative methods if
current methodology does not adequately address a research question. In addition, the core will facilitate
the management and updating of the clinical sarcoma database in collaboration with the leaders of
research projects and the other three cores of the Soft Tissue Sarcoma SPORE.

Public health relevance
Core 2: Biostatistics and Bioinformatics NARRATIVE The Biostatistics & Bioinformatics Core will support investigators of the Soft Tissue Sarcoma SPORE in the computational and statistical aspects of their research efforts, including the design and analysis of laboratory experiments, molecular profiling assays, and clinical trials. Its support is critical to all research projects in the Soft Tissue Sarcoma SPORE.